Cell-type-specific NRXN1alpha alternative splicing changes in psychiatric disease

PROJECT SUMMARY
Schizophrenia, bipolar disorder and autism are common and debilitating neurodevelopmental disorders that
together affect more than 5 million Americans. Despite more than fifty years of research, no cures exist and the
standard of treatment remains unsatisfactory. Heterozygous mutations of neurexin-1 (NRXN1) have been
repeatedly associated with schizophrenia (SZ) and autism spectrum disorder (ASD). The clinical presentations
of NRXN1+/- mutations (including diagnosis, severity, prognosis and age-of-onset) in affected patients are
diverse and the genetic mechanism affecting the penetrance of these mutations remains unknown. Moreover,
mouse models do not permit researchers to study how and why some NRXN1+/- deletions have more
deleterious effects in patients. Our objective is to resolve how NRXN1+/- deletions perturb the NRXN1 isoform
repertoire and impact neuronal maturation and synaptic function. Our preliminary data defined the NRXN1
alternative splice repertoire in control fetal and adult cortical tissue, and compared this to human induced
pluripotent stem cell (hiPSC)-derived neurons from NRXN1+/- cases and controls. Here, we propose to
evaluate the effect of experimental manipulation of the NRXN1 isoform repertoire in both control and NRXN1+/-
patient-derived excitatory and inhibitory neurons. Ultimately, we hope to directly correlate genomic and
functional deficits across increasingly refined populations of NRXN1+/- patient-derived neurons.

Public health relevance
PROJECT NARRATIVE Understanding the function in human neurons of the vast and cell type specific repertoire of NRXN1 isoforms produced by alternative splicing will provide a clearer understanding of how this gene contributes to neuropsychiatric disease. We have cataloged full-length NRXN1 isoforms of human adult and fetal cortical tissue and contrasted it with human induced pluripotent stem cell (hiPSC)-derived neurons from patients and controls, identifying psychiatric disease relevant differences in NRXN1 alternative splicing. Here, we propose to apply our hiPSC-based models to understand the functional effects of NRXN1 deletions in patient-derived excitatory and inhibitory neurons.